Neural Computations Underlying Vocal Sensorimotor Transformations

Project Summary/Abstract
This project aims to investigate the circuit mechanisms enabling an ethologically relevant sensorimotor
transformation. Specifically, we characterize the neural basis for rapid vocal exchanges in the singing
mouse (Scotinomys teguina), a highly vocal neotropical rodent species capable of producing an audible,
stereotyped song. Pairs of S. teguina often precisely coordinate the timing of their vocalizations in a process
known as countersinging. In preliminary work, we revealed a short-latency pathway from an orofacial region
of motor cortex to the muscles involved in vocal production. In this proposal, we will test the hypothesis that
neural dynamics in motor cortex, guided by selective acoustic cues, can modify downstream song
production circuits to enable rapid vocal communication across individuals. From these studies, we will
perform the first characterization of the circuit mechanisms underlying rapid vocal exchanges in a
mammalian model system.
In Aim 1, we will characterize the acoustic aspects of song that elicit countersinging behavior. We will
examine responses to the playback of a range of natural and synthetic sensory stimuli to test perceptual
boundaries and factors leading to vocal responsiveness.
In Aim 2, we will use several complementary perturbations to address the role of motor cortex on vocal
production and countersinging coordination.
In Aim 3, we will use population recordings to examine the responses of cortical neural populations
during vocal perception and production. We will then characterize the broader neural circuitry leading to
countersinging by uncovering both upstream and downstream synaptic partners.

Public health relevance
Project Narrative We will investigate the neural mechanisms that enable a cortically-mediated ethologically- relevant sensorimotor transformation in the mammalian brain, potentially informing our understanding of the brain processes involved in vocal interactions more broadly. Thus, the proposed research is relevant to the NIH’s mission to contribute to the body of knowledge needed to help those who experience communication disorders.